Nickel Cross-Coupling Cascades with α-Heteroatom Radicals to Prepare Sterically Hindered Alcohols and Amines

Project Summary
The overarching theme of this proposal is to apply robust and reliable reaction mechanisms to improve the
efficiency of forming C–C bonds adjacent to alcohol or amine functionality. Among the most common strategies
to these products is the addition of a Grignard reagent (or other carbon nucleophile) to a ketone or ketimine
electrophile, but the broad applicability of these methods is limited by (1) the poor compatibility of organometallic
nucleophiles with many functional groups common to drug scaffolds and (2) significant limitations inherent to
migratory insertion mechanisms, such as sluggish or undesired reactivity. The central hypothesis of this proposal
is that α-heteroatom radical generating processes can be implemented in tandem with nickel cross-coupling for
C–H functionalization to install hindered stereocenters. The emergence of nickel catalyzed cross-electrophile
coupling strategies has provided novel and complementary reactivity to traditional cross-couplings and the
controlled generation of organic free radicals is central to the development of new methods in this area.
Intramolecular hydrogen atom transfer (HAT) mechanisms proceed at a higher rate than nickel capture of alkyl
radicals, and should be an appropriate approach to generate the radical. The Specific Aims of this proposal are:
(1) development of a 1,5-HAT and nickel C–C bond forming cascade to synthesize tertiary alcohols from readily
available secondary alcohols and a traceless auxiliary group; (2) a strategy in which α-heteroatom radicals
formed through 1,5-HAT are intercepted for nickel facilitated C–C bond formation to prepare functionalized amino
alcohols and amino acids; and (3) an approach for Csp3–Csp3 coupling of α-heteroatom radicals to primary
radicals is presented, in which cross-selectivity should be driven by radical stability differences. All three of these
Aims can be adopted into enantioconvergent reactions by employing chiral ligands to generate stereocenters,
which is highly desirable in the context of pharmaceutical and natural product synthesis. The development and
synthesis of drug candidates is limited by the reactions available to make them, and the strategies described in
this proposal will facilitate Csp2–Csp3 and Csp3–Csp3 bond formation at α-heteroatom carbon centers, an
important motif found in pharmaceuticals and bioactive natural products. The continued improvement of catalytic
conditions that employ a large pool of coupling partners to prepare sterically congested alcohols and amines will
be of significant interest to both academia and industry, and will enable broader chemical space accessible in
future drug discovery endeavors.

Public health relevance
Project Narrative This proposal outlines nickel-catalyzed carbon-carbon bond-forming strategies to synthesize hindered stereocenters with α-heteroatom functionality. These motifs are abundant in drug scaffolds and biologically active molecules but can be challenging to efficiently prepare through current methods. Expediating their syntheses will broaden the accessible chemical space in the development of novel pharmaceutical candidates.